Impact of Colchicine on Peri-Operative Major Adverse Cardiovascular Events in Patients with Prior Coronary Revascularization

Patients with prior coronary revascularization have a high risk of major adverse cardiovascular
events (MACE) after major surgery, up to more than 2-fold when compared to patients without
prior coronary revascularization. The pro-inflammatory and hypercoagulable states induced by
surgery and the hemodynamic changes caused by fluid shifts and anesthesia are all important
triggers of perioperative myocardial ischemia. Indeed, peri-operative systemic inflammation is
associated with a nearly 4-fold increase in the risk of perioperative MACE. Neutrophils, the most
abundant of inflammatory cells, adhere to inflamed or injured endothelium, migrate into the
vessel wall, release proteolytic enzymes that can lead to erosion or rupture of plaque. Peri-
operative cytokine generation may also activate the inflammasome and, thereby, macrophage-
mediated synthesis of interleukin (IL)-1β, a known target for therapy for secondary prevention of
MACE, particularly in the setting of high C-reactive protein (CRP) concentration.
Colchicine is a safe, well-tolerated anti-inflammatory agent that preferentially accumulates in
neutrophils compared with other inflammatory cells. Colchicine inhibits chemotaxis, endothelial
adhesion, and extravasation of neutrophils at sites of endothelial injury or inflammation;
suppresses the inflammasome-mediated production of IL-1β by macrophages; and reduces
inflammation and MACE in patients with cardiovascular disease. The Colchicine Cardiovascular
Outcomes Trial and Low Dose Colchicine 2 Trial demonstrated a reduction in MACE with
colchicine in about 4000 patients with prior myocardial infarction and about 5000 patients with
stable coronary artery disease, respectively. My VA CDA-funded Colchicine-PCI trial
demonstrated for the first time that administration of colchicine prior to injury dampens the
inflammatory response measured by CRP. The effects of colchicine on peri-operative MACE in
patients with prior coronary revascularization undergoing major surgery, remains unknown.
The aims of this proposal are to 1) assess the effect of colchicine on peri-operative MACE in
response to intermediate- or high-risk non-cardiac surgery in patients with prior coronary
revascularization; 2) characterize the level of systemic inflammation and profile of peri-operative
neutrophils in this population; and 3) determine the clinical and genetic predictors of peri-
operative MACE and examine factors that determine heterogeneity of treatment response in this
population. This proposal offers the opportunity to use colchicine to delineate the role of
inflammation in the development of post-operative inflammation, as well as test this potentially
cost-effective therapy in the reduction of peri-operative MACE with minimal systemic
immunosuppression. The proposal also aims to foster a personalized medicine approach to
peri-operative cardiovascular optimization based on use of inflammatory markers and
pharmacogenetics to identify factors that predict patients who are at risk of peri-operative MACE
despite the use of colchicine and may, therefore, require alternative anti-inflammatory or anti-
thrombotic therapy. Finally, findings from this study may also open a door to novel therapeutic
strategies in other settings of cardiovascular inflammation and injury (e.g., peripheral artery
disease, stroke) and other disease states in which neutrophils play a pivotal role (e.g., vasculitis,
wound healing).

Public health relevance
Heart disease remains the leading cause of death in Veterans. Inflammation in the arteries of the heart may increase the risk of cardiac death. Patients with heart disease undergoing major surgery are at increased risk of complications after surgery, including heart attack, stroke, and death. The proposed research seeks to better understand the role of inflammation in the damage to the heart and blood vessels after major surgery. This research also seeks to identify the potential beneficial role of a safe medication, colchicine, which has direct effects on inflammatory cells and has been used in the treatment of inflammatory diseases for more than 2000 years, on reducing the rate of complications after surgery. With its quick onset of action and excellent safety profile, colchicine may have the potential to reduce risk of heart injury, stroke, or death after major surgery.